Deciphering mechanisms of myoblast fusion

Project Summary/Abstract
Despite the importance of myoblast fusion for normal muscle development and physiology, relatively little is
known about the molecules that directly function to remodel membranes during the myoblast fusion reaction.
Elucidation of fusion mechanisms is critical to fully understand muscle development and to identify novel
therapeutic strategies to augment skeletal muscle disease. We previously discovered that myomaker (Mymk)
and myomerger (Mymx) are essential for the fusion of skeletal muscle progenitors. Moreover, ectopic
expression of these two membrane proteins induces fusion of otherwise non-fusogenic cells (fibroblasts). For
the first time, this establishes a cell-based reconstitution system with myoblast fusogens, however many
questions exist as to how these two proteins induce fusion. We have recently found that myomaker and
myomerger drive fusion through a unique cellular mechanism, by dividing their independent membrane
remodeling activities to distinctly impact the fusion process. It stands to reason that the membrane-remodeling
activities of myomaker and myomerger must be highly regulated or they could have the potential to
compromise cellular integrity. With this supplement, we will expand our program to identify novel factors that
regulate fusion in skeletal muscle tissue. Overall, this work promises to open up a new area of investigation
into the cell biology of muscle and positively impact the possibility to harness fusion to improve regenerative
medicine.

Public health relevance
Project Narrative Fusion of myoblasts is an essential process for muscle development and regeneration. The goal of this project is to expand our knowledge on the factors that regulate fusion in muscle and their mechanisms of action.